Effect of slip bonds due to type 2B von Willebrand Disease on platelet adhesion, aggregation, and contractile forces

PROJECT SUMMARY/ABSTRACT
Von Willebrand Disease (VWD) is characterized by a defect in the blood protein von Willebrand Factor (VWF)
and leads to uncontrolled bleeding. VWF is necessary for initial platelet tethering and subsequent platelet
adhesion to the injured vasculature. Glycoprotein Ib (GPIb) is a receptor found on the platelet surface that
recognizes the A1 domain of VWF. When the vascular endothelium is damaged, VWF binds to exposed fibrillar
collagen and to GPIb, tethering the platelet to the surface. Then, cytoskeletal forces acting through integrin αIIBβ3
allow platelets to adhere and aggregate, forming a strong and stable platelet-rich plug. The GPIb-A1 bond forms
under conditions of high shear and is characterized as a “catch” bond, meaning it has a longer lifetime under
conditions of increased tensile force. In type 2B VWD, a gain-of-function mutation to VWF causes an increased
affinity for platelet binding at low shear. The type 2B VWF mutation leads to spontaneous platelet binding and
subsequently uncontrolled bleeding. Previous work has demonstrated that with type 2B VWD, VWF and GPIb
no longer form a catch bond but instead a “slip” bond, which is characterized by a shorter bond lifetime under
conditions of increased tensile force. Additionally, platelet cytoskeletal forces can act independently of integrin
αIIBβ3 through the GPIb-A1 bond. However, prior work has failed to fully explain how slip bonds in type 2B VWD
affect the mechanics of platelet adhesion and platelet plug formation. I hypothesize that changes in the force-
lifetime relationship of GPIb-A1 bonds due to type 2B VWD will affect platelet adhesion and aggregation
due to an inability to withstand cytoskeletal forces. Platelet adhesion and contractile force will be measured
at the single platelet level using flexible, cantilever-like nanoposts, while the contractile force generated by a
platelet aggregate will be quantified using a microfluidic device. Using these methods, I can characterize how
the biomechanics of platelet plug formation are affected by type 2B VWD, further explaining the bleeding
phenotype. In the future, this knowledge relating to hemostasis initiation can be utilized to diagnose or treat type
2B VWD.

Public health relevance
PROJECT NARRATIVE 1% of the population is affected by von Willebrand Disease (VWD) which is a bleeding disorder caused by a shortage or defect in von Willebrand Factor (VWF), a blood protein involved in hemostasis. Specifically, type 2B VWD is described by a gain-of-function mutation leading to spontaneous VWF-platelet binding, which causes an uncharacteristic “slip” bond, meaning the bond lifetime decreases with increasing tensile force. Because VWD is difficult to diagnose, costly to treat, and has no cure, this research is important to (1) target a better understanding of platelet biomechanics in type 2B VWD, (2) quantify platelet adhesion, aggregation, and contractile force under shear flow, (3) develop diagnostic techniques for type 2B VWD, (4) explore therapeutic approaches for type 2B VWD, and (5) further investigate VWF-platelet interactions, which play an important role in hemostasis and thrombosis.